Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core will provide overall guidance, administrative support, project integration, and fiscal
management for the UNC TCORS. Dr. Kurt M. Ribisl will be the Leader of the Administrative Core. Dr. Ribisl is
an accomplished researcher and leader who has 28 years of experience in tobacco regulatory science,
including success in serving as Principal Investigator (PI) or Multi-PI on three large center grants. The
Administrative Core will ensure integration among our efforts by providing the infrastructure and management
necessary for coordinating the day-to-day operation of our Center, which includes four Research Projects and
two Cores. The Administrative Core will ensure that our Projects and Cores maximize collaboration, promote
synergy among Projects, help administer career enhancement activities and pilot projects, coordinate with our
External Advisory Board, and stimulate effective research dissemination activities.
The Specific Aims of the Administrative Core are to: (1) Foster communication and integration among the
UNC TCORS Projects and Cores, across other funded TCORS, with the TCORS Coordinating Center, and
with the FDA and NIH staff, (2) Ensure that Center Research Projects address disparities in tobacco use, and
(3) Translate and disseminate research to support tobacco regulatory policy.
The Administrative Core will provide the infrastructure and management necessary to coordinate the
operations of our Center to accomplish our study Aims and achieve our vision of identifying effective tobacco
regulatory and communication strategies to reduce and eliminate tobacco-related disparities. UNC TCORS
investigators have substantial expertise and proven track records in conducting collaborative, interdisciplinary
tobacco regulatory science and in disseminating the study findings to broad constituencies.